mHealth Technologies for Assessing Blood Perfusion in Chronic Wounds

Project Abstract
Approximately 8.2 million Americans suffer from chronic wounds. Chronic wounds can be difficult to treat, and if
left untreated, they can lead to serious infections, tissue damage, and even amputation. Besides, the cost of
managing chronic wounds is very high – which requires frequent visits to healthcare providers, specialized
wound care products, and in some cases, hospitalization. This can place a financial burden on both patients and
the healthcare system. Blood perfusion, or the flow of blood to the tissues, is a critical factor in the healing of
chronic wounds. Chronic wounds often result from poor blood flow to the affected area, which can lead to a lack
of oxygen and nutrients necessary for the healing process. The long-term objective of this project is to improve
wound care and impact wound treatment services by developing low-cost technologies that aid with chronic
wound treatment and care. The primary objective of this application is to design, implement and validate
mHealth-based blood perfusion assessment tools to empower individuals with chronic wounds in daily life.
Building on our prior work, in this project we will enhance and validate a smartphone-based multi-spectral
imaging sensor to obtain perfusion-related measures (Aim 1), conduct a clinical study to validate mHealth-based
biomarkers with machine learning algorithms (Aim 2), and rigorously assess the tools in usability and learnability
(Aim 3). The approach is innovative because it will explore and validate new mobile computing and data-driven
techniques for wound care and blood perfusion assessment based on evidence-based ground truth. It holds the
potential to advance the current standard of wound care for recovery after discharge from clinical therapies.
These contributions are significant because they can extend the health self-management of our society through
proactive health care and real-time intervention, and reduce the subjective bias and financial burden for patients,
caregivers, and society.

Public health relevance
Project Narrative There is an unmet need for a low-cost system that can access tissue perfusion during chronic wound care during telehealth consultations. We will implement and validate a smartphone-based system to characterize functional and structural information about the wound, such as vascular structure and hemoglobin in the vessel’s bloodstream. The technology can lead to faster and more precise measurement of wound healing to optimize medication and therapy interventions.